The Center for Neuroscience-based Mental Health Assessment and Prediction (NeuroMAP)

PROJECT SUMMARY: Overall
Mood and Anxiety Disorders are the most prevalent and disabling mental health conditions worldwide, yet
there are limited explanatory and predictive disease models available for these conditions. The theme of the
Neuroscience-based Mental Health Assessment and Prediction (NeuroMAP) CoBRE is based on the premise
that experimental designs that use transdiagnostic approaches (i.e., processes that cut across disease
categories) with multiple levels of analyses (symptoms & behavior, circuits & physiology, cells & molecules)
can identify disease modifying processes that can become targets of interventions. Phase I of NeuroMAP
recruited 8 RPLs and 8 PPIs. As of 6/2022, they applied for 99 extramural grants, received 8 federal grants,
and published 130 papers linked to the P20. Two underrepresented minority investigators using NeuroMAP
Core data received prestigious Maximizing Opportunities for Scientific and Academic Independent Careers
(MOSAIC) K99/R00 awards. Prior to the NeuroMAP CoBRE (funded 9/15/2017) the annual NIH funding for
LIBR was $662,104 (NIH Reporter accessed 6/17/2022), for 2021/22 the annual funding is $7,555,510
($5,368,214 without the CoBRE), which is a 11.4 (8.1)-fold increase. The goal for Phase II of the NeuroMAP
is to maintain and expand the infrastructure for RPLs. The Specific Aims of NeuroMAP are: (1) To expand
the critical mass of investigators that are focused on Neuroscience-based Mental Health Assessment and
Prediction approaches to mood and anxiety disorders. (2) To provide an operational infrastructure that
provides the tools necessary to conduct research projects, standardize assessments, and provide a data
repository for future pilot projects. (3) To provide a mentoring and career development infrastructure to junior
investigators to conduct studies focused on targetable, disease modifying processes in mood or anxiety
disorders. NeuroMAP will consists of: (a) an Administrative Core (Paulus); a Recruitment and Assessment
Core (Aupperle & Khalsa), a Circuit and Molecules Core (Rohan & Savitz), and a Data Management and
Statistics Core (Kuplicki & Thompson). There are three proposed projects: (1) Transcranial Direct Current
Stimulation: Threat Sensitivity target (Ironside) - External Mentor: Monique Ernst, NIMH; Internal Mentor:
Robin Aupperle, LIBR. (2) The effects of aversive interoceptive states on the computations and associated
neural basis of avoidance behavior (Smith) - External Mentor: Philip Corlett, Yale University; Internal Mentor:
Jennifer Stewart, LIBR. (3) Modulating repetitive negative thinking related brain networks in young adults
with depression (Tsuchiyagaito) - External Mentor: Kate Fitzgerald, University of Michigan; Internal Mentor:
Jonathan Savitz, LIBR. The goal of Phase II is to expand research in mood and anxiety disorders, build a
bigger base of funded investigators, and to attract more young talent to delineate the processes that
contribute to individuals developing, recovering from, and relapsing to mood and anxiety disorders.

Public health relevance
PROJECT NARRATIVE: Overall The Center for Neuroscience-based Mental Health Assessment and Prediction (NeuroMAP) seeks 5 years of support to continue and expand the scientific infrastructure in Tulsa, OK, to help young investigators develop research projects focused on identifying biological causes and predictors of anxiety and mood disorders. Tulsa is still an under-developed region for mental health research even though Oklahoma has the second highest rate of mental illness in the country. The NeuroMAP Center will continue a program to train junior researchers with a pragmatic focus to use neuroscience to improve mental health.